THE BALTIMORE LONGITUDINAL STUDY OF HUMAN AGING

The Baltimore Longitudinal Study of Human Aging (BLSA) serves as a resource for scientists working in the field of Gerontology. It provides a well-described group of men and women between 20 and 96 years of age for studies of the mechanisms of human aging. Projects in physiology, biochemistry, psychology, nutrition, pharmacology, endocrinology, sociology, and genetics, have been carried out or are in progress.